DEVELOPMENT OF TANDEM MASS SPECTROMETRY

Development of Techniques Using (1)Kratos Tandem Double-Focussing Mass Spectrometer System with Multi-Channel Array Detection and Sun Data Workstation; and (2)VG Autospec 5000 tandem octhogonal acceleration ToF. a) Proteins b) Carbohydrates c) Glycoconjugates (Additional effort and instrument time reported under Collaborative projects and other Technical Research and Development projects.)